ANALYSIS OF SINGLE STRANDED AND DUPLEX DNA

Methods were developed for measuring single stranded and duplex DNA by electrospray ionization mass spectrometry. Mass spectrometric analysis of DNA was found to be sensitively dependent on the nature of cations in the spray solution, the ionic strength of the spray solution, and conditions within the electrospray ion source.